Regulation of alpha7 nAChRs and NACHO

Tsunoda, Susan
Project Summary
Nicotinic acetylcholine receptors (nAChRs) are involved in a wide range of physiological processes, from
motor activity to complex brain functions, including learning/memory function and attention. nAChRs have also
been shown to mediate homeostatic synaptic plasticity (HSP), a protective mechanism stabilizing neural activity.
As such, dysfunction or loss of nAChRs has been implicated in a variety of neurological diseases. For example,
the α7 nAChR has been implicated in Alzheimer’s Disease, nicotine addiction, nicotine-induced seizures, as well
as schizophrenia. Indeed, enhancing nAChR signaling is a long-validated approach to treating multiple
neuropsychiatric/pathological disorders. Despite this importance, much remains to be understood about how
nAChRs are assembled and trafficked to the plasma membrane in neurons, especially when neurons encounter
changes in activity. The proposed studies focus on NACHO, a newly identified endoplasmic reticulum (ER)-
resident protein, shown to be a client-specific chaperone of nAChRs, and essential for trafficking α7 nAChRs.
We use molecular-genetic approaches in Drosophila to overcome some of the limitations of studying intracellular
α7 nAChRs in mammalian neurons. We: 1) examine the temporal relationship of NACHO and α7 nAChR up-
regulation during HSP, 2) test whether NACHO and α7 depend on one another during HSP and whether one is
sufficient to up-regulate the other, and 3) examine how the localization of α7 and NACHO in the ER/Gogli
changes during HSP.

Public health relevance
Tsunoda, Susan Project Narrative Nicotinic acetylcholine receptors (nAChRs) are involved in a wide range of physiological processes, from motor activity to complex brain functions, including learning/memory function and attention. Dysfunction or loss of nAChRs has been implicated in a variety of neurological diseases, including Alzheimer’s Disease, nicotine addiction, familial epilepsy, depression, and schizophrenia. Enhancing nAChR signaling is a long-validated approach to treating multiple neuropsychiatric/pathological disorders, yet, despite this importance, much remains to be understood about how nAChRs are assembled and trafficked to the plasma membrane in neurons. The proposed studies focus on NACHO, a newly identified endoplasmic reticulum (ER)-resident protein, shown to be a client-specific chaperone of nAChRs. Mechanisms revealed by these studies may provide alternate approaches to regulating levels of nAChRs for therapeutic treatment.